Role of FGF21 Action in Hypothalamic Neurons in Obesity-Associated Hypertension

Project Summary / Abstract
Hypertension affects one billion people and is a principal reversible risk factor for cardiovascular disease.
Obesity which has become common in the US and throughout the world is a major cause of hypertension, but
the mechanisms underlying the relationship between obesity and hypertension remain largely unknown. The
goal of this proposal is to identify the neuronal and molecular processes that control blood pressure and how
dysregulation in these processes contribute to obesity-associated cardiovascular risks. This proposal is based
on the hypothesis that obesity-induced elevation in the hormone fibroblast growth factor 21 (FGF21) promotes
hypertension by activating ventromedial hypothalamic neurons expressing steroidogenic factor 1 (SF1) to
increase sympathetic nerve activity. We will use a multidisciplinary strategy combining cutting edge neuro-
technologies to precisely and remotely modulate or monitor the activity of SF1 neurons in freely moving
animals with unique genetically engineered mouse models that permit selective modulation of FGF21 signaling
in SF1 neurons and sophisticated integrative physiology for sympathetic and cardiovascular phenotyping. We
plan to test our central hypothesis by determining how chemogenetic- or optogenetic-mediated activation or
inhibition of SF1 neuron activity affects sympathetic outflow and arterial pressure under normal conditions as
well as in obesity. We will also explore the contribution of FGF21 signaling in ventromedial hypothalamus
including SF1 neurons to sympathetic and arterial pressure control and obesity-associated hypertension and
sympathetic nerve activation. This work should unravel novel mechanisms that underlie obesity-associated
sympathetic activation and hypertension, making our work of high clinical relevance. Insights into the cellular
and molecular processes that control the sympathetic tone that regulates cardiovascular function may make it
possible to selectively interfere with the damage obesity inflicts on cardiovascular sympathetic functions.

Public health relevance
Project Narrative Obesity which has become extremely prevalent in the United States is a major trigger of high blood pressure which is a leading cause of heart attacks, heart failure and stroke. The focus of this project is to explore the processes employed by the brain to regulate blood pressure and understand how dysregulation in these processes cause high blood pressure in obesity. Thus, this proposal should fundamentally advance our understanding of the mechanisms that underlies the cardiovascular diseases caused by obesity.